High-throughput bioengineering technologies for vision restoration

DESCRIPTION (provided by applicant): Retinal degenerations collectively represent the leading cause of irreversible vision loss worldwide, and there is no FDA approved treatment to replace damaged retinal cells. Our long-term goal is to identify a safe and efficient method to generate RPE replacement cells. The hypothesis of this proposal is that a combination of defined factors can covert fibroblasts into functional iRPE. The Aims of this proposal are to 1) Utilize high-throughput assays to comprehensively screen a transcription factor library and small molecule library for candidates that can convert fibroblasts into RPE replacement cells and 2) determine if RPE replacement cells perform similarly to authentic RPE cells.

Public health relevance
PUBLIC HEALTH RELEVANCE: Macular degeneration is a leading cause of vision loss. This proposal attempts to generate safe and effective retinal replacement cells that can be used to treat retinal degenerations.